MOLECULAR MECHANISMS OF THIAMINE UTILIZATION

To elucidate the pathophysiology of diverse thiamine deficiency related diseases, we are investigating the molecular interactions of thiamine utilizing enzymes with the thiamine pyrophosphate (TPP) cofactor. A reduction in the activities of thiamine-requiring enzymes has been implicated as the metabolic basis of tissue injury due to thiamine deficiency.